Experimentally-validated model of glymphatic disruption due to spreading depolarization

Project Summary/Abstract
Spreading depolarization (SD) occurs following many acute neurological conditions and is characterized by the
loss of ion gradients across neuronal and astrocytic membranes. Recently, SD following stroke and cardiac arrest
has been linked to acute edema formation via excess inﬂux of cerebrospinal ﬂuid (CSF). This CSF is pulled into
the brain via the glymphatic system, which is a network of perivascular spaces (annular channels around vascu-
lature) connecting subarachnoid CSF with the brain interstitium. The mechanisms by which SD pulls CSF into
the brain are not well-understood. On the other hand, studies of migraine with aura indicate that SD can severely
diminish glymphatic function. To reconcile these seemingly contradictory results, we hypothesize that SD results
in three dominant competing effects that enhance or diminish glymphatic CSF ﬂow: potassium ion-dependent
vasodilation/vasoconstriction, swelling of astrocyte endfeet, and osmotic pressure gradients in surrounding brain
tissue. To disentangle the signiﬁcance of each effect experimentally, we propose the development of a novel
numerical simulation that couples a physiologically-realistic SD model to a detailed simulation of the glymphatic
system. We will do so by implementing and extending an existing physiologically-based model of SD to simulate
the spatiotemporal evolution of the concentration potassium, sodium, and chloride ions (Aim 1). We will then cou-
ple the SD model to an existing ﬂuid network model to capture disruption to the glymphatic system (Aim 2). This
network model will implement the three SD-related competing effects described above. Finally, we will perform in
vivo experiments with transgenic mice using two-photon microscopy to quantify vasculature/PVSs, SD propaga-
tion, and alterations to CSF ﬂow speed which will parameterize and validate our simulations. Development of this
validated simulation will constitute the ﬁrst comprehensive model of SD-induced glymphatic disruption, offering
fundamental insights into competing mechanisms of enhanced/diminished glymphatic ﬂow. In turn, this model
will lead to development of experimentally-testable hypotheses for mitigating SD-induced alteration to CSF ﬂow
in a variety of neurological conditions.

Public health relevance
Project Narrative Spreading depolarization is a slow-moving wave of abnormal electrical activity in the brain that occurs in many neurological conditions such as stroke. Recent experiments show that this phenomenon pulls cerebrospinal ﬂuid into the brain, killing additional brain cells, but the underlying mechanisms of this phenomenon are not understood. We will use simulations and mouse experiments to uncover the relative importance of three different likely mechanisms that lead to disruptions in the cerebrospinal ﬂuid ﬂow due to a spreading depolarization wave.